Individualized Care for At Risk Older Adults

For the foreseeable future, addressing the complex health and social needs of the growing population of older
adults with multiple chronic conditions (MCCs) and supporting their family caregivers, especially during
frequent transitions in health, is a societal priority. This T32, Individualized Care for At-Risk Older Adults,
based at the University of Pennsylvania School of Nursing (SON) where expertise in aging and transitional
care research are hallmarks of our faculty, is uniquely designed to prepare nurse scholars who will address this
challenge. Since 2007, this program has successfully prepared 15 PhD graduates and 13 postdoctoral fellows
who are now pursuing successful scholarly careers and advancing science related to health and health care
transitions of older adults. This proposed renewal, led by two highly experienced nurse scientists is supported
by nine additional core and eight associated faculty in the SON with complementary programs of research. Our
emphasis on team science is actualized with co-mentored training from 25 interprofessional Penn faculty
external to nursing. Guided by the AHRQ Multiple Chronic Conditions Research Network's conceptual model,
our training program will prepare four predoctoral and four postdoctoral nurse scientists appointed annually
with the skills and knowledge to: 1) advance science related to the impact of frequent and complex transitions
in health and health care on older adults with MCCs and their family caregivers, with particular emphasis on
the role of nurses; 2) conduct research with the highest standards of rigor and integrity, using a team science
approach, and employing contemporary and emerging research designs and methodologies; and 3) perform
synthesis, dissemination, implementation and translation of research findings designed to inform and improve
health care practices and policies. This renewal builds on our success and is responsive to dynamic
population, research, and health care system changes through innovative program modifications. Specifically,
this renewal expands the program's emphasis on care of chronically ill older adults to focus on the complex
health and social needs of the growing population of older adults with multiple chronic conditions and their
family caregivers. Further, we emphasize the longitudinal care of diverse and vulnerable subgroups of older
adults with MCCs throughout multiple health transitions. We enhance our current training in research methods
to include: (a) a broader range of designs with enhanced translational potential; (b) advanced data science; (c)
sophisticated qualitative and mixed methods; and, (d) rigorous measurement of outcomes. Current attention to
dissemination of individual study findings extends to a more robust focus on knowledge synthesis,
implementation, and translation. The rich scientific base, resources and networks contributed by committed
faculty mentors provide an excellent foundation and environment for this training grant. Building on our prior
success, we will produce nurse scientists and leaders prepared to contribute scientific advances designed to
have a major, positive impact on the care and outcomes of older adults with MCCs and their family caregivers.

Public health relevance
For the foreseeable future, addressing the health and social needs of the growing population of older adults with multiple chronic conditions and supporting their family caregivers is a societal priority. Building on our success since 2007, we will continue to prepare nurse scientists with the knowledge, skills, and abilities to design and conduct rigorous research to advance science related to the impact of frequent and complex transitions in health and health care on older adults living with multiple chronic conditions and their family caregivers. The rich scientific base, resources and networks contributed by committed faculty mentors provide an excellent foundation and environment for this training program.